Characterization of human DRG at the single cell level via integrated transcriptomics and spatial proteomics

Project Abstract – Project 2
Rodent models of dorsal root ganglia (DRG) have been extremely useful in identifying the cellular and molecular
mechanisms involved in pain, nerve injury, regeneration, degeneration, and various forms of peripheral
neuropathies. However, translation of preclinical findings may be greatly improved by validation in human tissues.
Since differences exist between rodent and human sensory neurons, a detailed study of all cells within human
DRG is critical for future treatment of painful state, nerve injuries as well as peripheral neuropathies. The difficulty
to gain access to human DRG has hampered progress on that front. Our collaborative team is uniquely positioned
to tackle this problem. We have gained expertise in the surgical procedure for extraction of human DRG from
organ donors consenting to tissue donation for research and the preparation of viable adult DRG cells for
functional and molecular studies. Combined with our strong expertise in single cell sequencing, imaging mass
cytometry and bioinformatics approaches, we will define at the single cell level the molecular profile of neuronal
and non-neuronal cells within human DRG tissue. We will integrate gene expression profile with imaging mass
cytometry (IMC), a tissue-based proteomic analysis that allows the detection of over 30 protein markers
simultaneously on tissue sections at the single-cell level while retaining the spatial relationships of the cells. IMC
enables a variety of distinct cell types to be analyzed concurrently at a single-cell resolution and is reshaping the
ability to interrogate both the intercellular interactions and the architectural relationships between cells and their
native microenvironment. This spatially-resolved multiplexed profiling approach has been applied to cancer,
diabetes, immunology, and infectious disease research, identifying functionally distinct immune cell
subpopulations associated with disease progression, treatment outcomes, and biomarkers for disease prognosis.
We will develop computational approaches for integrated IMC and single cell transcriptomic analysis of hDRG.
Application of this spatially-resolved, highly multiplexed, single-cell transcriptomics and proteomic profiling
approach to pain research will likely reshape our ability to interrogate cell population and gene expression
changes and their spatial relationships between neurons and non-neuronal cells in healthy and painful conditions.
By integrating the cellular, spatial and functional branches of the human DRG atlas we will dramatically expand
the characterization of human DRG in healthy and painful states. This project will generate a reference atlas for
human DRG and define inter-individual variability of healthy human DRG tissue and DRG from painful conditions
with single cell resolution.